Precision Genome Engineering

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Precision Genome Engineering, organized
by Drs. Morgan Maeder, Benjamin Kleinstiver and Kiran Musunuru. The conference will be held in Banff,
Alberta, Canada from January 22–25, 2024.
The Keystone Symposium on Precision Genome Engineering has become one of the leading conferences in
the genome editing field. This regularly occurring conference is established as a premiere forum for featuring
gene engineering technology development and the preclinical application of these tools. As a result, the
conference has a primary aim of bringing together a diverse group of scientists with expertise that will facilitate
the application of genome editing approaches in human patients. Because delivery of gene-targeting reagents
presents a salient challenge for implementation of genome editing in the treatment of human disease, this
conference will be held jointly with a related conference, entitled Delivery of Nucleic Acid Therapeutics. This
pairing is ideal as it will stimulate discussion and collaborative innovation between two fields which have
traditionally been distinct but are becoming increasingly connected as gene editing moves into the clinic.
Through these joint conferences, attendees will gain a deeper understanding of the current state of research in
these related fields, have the opportunity to strategize about the major challenges in the area and forge cross-
disciplinary connections that will lead to innovative solutions to these challenges.

Public health relevance
PROJECT NARRATIVE Therapeutic genome engineering holds the potential to revolutionize the treatment of genetic diseases, from ultra-rare diseases to common leading causes of death, such as heart disease and cancer. It will also lead to significant advances in drug discovery by allowing researchers to more accurately model diseases, identify potential drug targets and test new therapies. This Keystone Symposia conference will bring together experts in technology development, therapeutic applications, and clinical translation to foster deeper understanding of what the current tools are capable of and how best to deploy them to treat human disease.